Developmental Synaptopathies Associated with TSC,PTEN and SHANK3 Mutations - supplement #2

Summary or Abstract of the Funded Parent Award or Project
Advances in genetics have illustrated that autism spectrum disorder (ASD) and intellectual disability (ID)
include a spectrum of rare disorders, and that mutations in hundreds of genes may result in susceptibility to
ASD/ID. This heterogeneity represents significant challenges, but at the same time unique opportunities for
research in the field of ASD/ID. Many of the genes implicated in ASD/ID appear to converge on a few common
pathways, suggesting that there may be a common dysfunction at the cellular or systems level. Deeper
understanding of the shared pathophysiology of these diseases may serve as gateways for understanding
mechanisms of other causes of ASD/ID and for shared treatment possibilities. The Developmental
Synaptopathies Consortium (DSC) was formed and funded in 2014 in order to perform mechanistic analysis of
three genetic disorders with high penetrance of ASD/ID, and shed light on molecular pathways and
mechanism-based therapeutic targets relevant to ASD/ID. We propose to continue our focus on three genetic
syndromes with abnormal synapse structure or function and that are associated with high penetrance for
ASD/ID: TSC1/2 (Tuberous Sclerosis Complex or TSC), PHTS (PTEN Hamartoma Tumor Syndrome or PHTS)
and SHANK3 (Phelan McDermid Syndrome or PMS) mutations. Specific aims for TSC are: 1) Characterize the
phenotype of ASD and ID in a large cohort of pediatric and adult patients with TSC in a prospective, multi-
center longitudinal design; 2) Identify electrophysiological biomarkers of synaptic function and connectivity
associated with ASD and ID in TSC; and 3) Evaluate the suitability of the TAND Checklist as TSC-specific
research tool for assessing clinically-meaningful outcomes in future ASD and ID clinical trials. Specific aims for
PHTS are: 1) Determine cross-sectional and longitudinal neurobehavioral and medical differences between
PTEN-ASD and other groups in an expanded age range; 2) Identify EEG and molecular biomarkers specific to
PTEN-ASD and those shared with other groups; and 3) Validate TAND and develop a comprehensive,
multilevel, longitudinal model of PTEN-ASD using data from Aims 1 and 2 and TAND scores to inform future
clinical trials and the development of consensus care guidelines. Specific aims for PMS are: 1)
Comprehensively characterize PMS across the lifespan and track the natural history; 2) Validate
electrophysiological biomarkers of PMS; and 3) Develop a comprehensive clinical model of PMS to inform
assessment and future clinical trials. As detailed in the Resources sections, this Consortium involves
experienced physician-researchers from premier academic institutions with strong institutional and patient
advocacy group (PAG) support, along with impressive mentors for training of future physician-researchers and
genetic counselors focused on translational research in neurodevelopmental disorders. We will continue to
work closely with the PAGs to engage and inform the families affected with these disorders. Knowledge gained
from this project will inform clinical practice and spur the development of novel treatments.

Public health relevance
Autism spectrum disorder (ASD) affects 1 in 59 children, and lifetime costs are estimated at >$3 million/person with >$35 billion in annual impact to US economy, representing a major public health challenge. We therefore seek with urgency to discover the underlying causes by focusing on genetic subsets of ASD, specifically the TSC1/2, PTEN and SHANK3 genes. Understanding of comparative disease pathophysiology is crucial for the identification of shared mechanisms for the various causes of ASD and intellectual disability, and ultimately for discovery of therapeutic targets.